The Human Pancreas Analysis Program for Type 2 Diabetes

Penn Human Pancreas Analysis Program – T2D
Abstract
Building on our existing infrastructure and scientific collaborations, and the expertise gained
during the first two years of the HPAP effort for Type 1 Diabetes, we have assembled five cores
with expertise ranging from pancreas procurement and islet isolation to data integration. These
Cores form a for a comprehensive and integrated Penn Human Pancreas Analysis Program –
T2D based entirely at the University of Pennsylvania. Core A will procure a spectrum of human
pancreata and detailed donor medical history; perform high resolution HLA typing by next
generation sequencing; isolate islets; and distribute islets and tissues to the other Cores for further
analysis or processing. Core B will perform physiological phenotyping on the isolated islets. Core
C will perform multiple advanced modalities for the molecular profiling of isolated islets including
RNAseq, ATACseq and DNA methylome analysis of sorted islet cell populations; single cell
ATACseq and RNAseq, and mass cytometry for single cell quantification of more than 20 cell
surface and intracellular markers. Core D will process tissues using multiple modalities that will
allow for analysis using advanced technologies such as multiplexed immunoflourescent staining,
whole slide imaging, and imaging mass cytometry. This Core will also archive tissues, DNA and
blood, as well as other T2D-relevant organs such as skeletal muscle, intestine, adipose tissue
and liver for future use by other NIDDK-approved consortia. Finally, Core E will assemble,
annotate and maintain an open-access database for the Program and its member-researchers,
and collaborate with the HIRN in the sharing of data from both programs. The entire program will
directed by an Executive Committee consisting of the core leaders and the PI, who will be the
interface with HIRN and NIDDK leadership. HPAP-T2D will provide physiologic, genomic, genetic,
and histological analysis of the pancreas in type 2 diabetes at unprecedented detail, share the
rich data with researchers world-wide before publication, and thus enable breakthrough
discoveries in our understanding of this disease that has reached epidemic levels world-wide.

Public health relevance
Penn Human Pancreas Analysis Program – T2D Narrative The past decades have seen a dramatic improvement in our ability to phenotype and molecularly profile human tissues relevant to the etiology of type 2 diabetes with unprecedented resolution, at the genomic, epigenomic, protein, and functional levels. Here we will employ state-of-the-art technologies to determine all aspects of pancreas biology as it pertains to type 2 diabetes, profile human pancreatic islets with multiple assay modalities, and make the vast data accumulated available through the highly accessible PANC-DB. This comprehensive profiling of the natural history of Type 2 diabetes will pave the way for future discoveries of new treatment modalities for diabetes.